Assessing the role of APOE in glial lipid droplet metabolism and function

Abstract
Lipid Droplets (LDs) and their associated proteins are known to play a major role in regulating lipid
metabolism and storage at the cellular level. Most cell types typically contain some LDs under homeostatic
conditions, but excessive accumulation of LDs can be indicative of several pathologies, depending on the tissue.
The majority of studies focused on abnormal accumulation of LDs have been conducted in the liver regarding
stenosis and non-alcoholic fatty liver disease (NAFLD), or adipose tissue in the context of obesity. However, the
accumulation of LDs has also been observed in the brains of individuals with Alzheimer’s Disease (AD), and
likely represent the “adipose saccules” in neuroglia first described by Dr. Alois Alzheimer.
The expression of a specific LD protein, Perilipin-2 (Plin2), has consistently been shown to correlate with
the presence and abundance of LDs within a cell or tissue. Plin2 to is known for being involved in the stabilization
of LDs and regulating the access of the LD to enzymes like lipases. Others have shown that modulating the
expression of Plin2 directly effects the accessibility and turnover of LDs, where higher levels of Plin2 expression
leads to accumulation and little turnover of LDs, and lower levels of Plin2 expression are associated with
increased LD turnover and fewer LDs overall. In mice, others have observed alleviation of diet-induced obesity,
adipose inflammatory foci, hepatic inflammation, and fibrosis in the liver through the conditional loss of Plin2 in
the adipose or liver tissue respectively. One study in particular shows that Plin2-/- mice given a cuprizone-
induced demyelinating diet have significantly increased levels of remyelination following the return to a normal
diet, and macrophages derived from these mice had fewer lipid droplets and displayed a less inflammatory
phenotype. To our knowledge, no studies have targeted neuroglia with a conditional Plin2 KO which leads us to
question how the loss of Plin2 would affect lipid droplet accumulation and dysregulated lipid metabolism
observed in aging and neurodegeneration. This is a key knowledge gap to understanding lipid metabolism in AD
which we hope to bridge through our proposed aims.
Specifically, we hypothesize that a reduction in Plin2 expression will alleviate several pathologies
associated with AD by increasing LD turnover and decreasing neuroinflammation. We will first generate novel
cell-specific Plin2 KO mice that we will then cross with 5xFAD mice to specifically remove Plin2 from either
astrocytes or microglia and determine the effects of Plin2 on AD. Then we will investigate how the removal of
Plin2 effects phagocytosis activity within microglia and either capacity to clear unwanted debris. Lastly, we will
determine the role that Plin2 plays on impairments commonly seen in cells carrying APOE4, the greatest
genetic risk factor for late-onset AD.

Public health relevance
Project Narrative Perilipin-2 (Plin2), a surface component of organelles known as lipid droplets, has been shown to accumulate in specific cells within the brains of Alzheimer’s disease (AD) patients and those with APOE4, a gene variant that increases risk of AD. Increased amounts of Plin2 indicates lipid accumulation and dysregulated metabolism. This project aims to determine the effects of lowering Plin2 in the specific brain cells on AD pathologies.